Hospice Use in Older Adults with Alzheimer's Disease and Related Dementias: Patterns, Policies, and Caregiver Experiences

PROJECT SUMMARY
Almost half of the over 1.5 million Medicare beneficiaries who enroll in hospice each year have Alzheimer’s
Disease and Related Dementias (ADRD). Yet, hospice is poorly suited to the needs of persons with dementia
(PWD) and remains stuck in a model of care designed around the needs of people with cancer. This poor fit
has resulted in worrisome patterns of hospice use among PWD, including very long length of stay (LOS) and
high rates of disenrollment. Long stays are a problem because they increase Medicare expenditures on
hospice, which has skyrocketed from $2 billion to almost $20 billion between 2000 and 2018. Disenrollment is
a problem because it disrupts continuity of care, creating burdensome transitions for patients and caregivers.
PWD, in whom prognosis is notoriously difficult to predict, have the longest average LOS in hospice (151 days
versus 53 days in cancer) and are four times more likely to experience disenrollment after long stays in
hospice than enrollees with cancer. Hospice Payment Reform of 2016—the first change to Medicare hospice
reimbursement structure since its inception—changed hospice reimbursement from a single per diem rate to a
tiered model and was intended to de-incentivize long stays in hospice. While qualitative evidence suggests that
Payment Reform and other regulatory approaches have disproportionately impacted hospice use patterns in
PWD, the specific impact of Payment Reform on length of stay and disenrollment in PWD is unknown. The
objective of this proposal is to evaluate the impact of Payment Reform on LOS and disenrollment in PWD, key
outcomes of interest to both payors and patients. We will build upon our longitudinal 100% cohort of almost 1
million Medicare Beneficiaries with dementia enrolled in hospice between 2012-2017 to add a cohort of people
with cancer and additional years following Payment Reform. We will complement these quantitative analyses
with qualitative interviews with dementia caregivers and hospice staff. The aims are: 1) Assess the impact of
2016 Payment Reform on hospice length of stay and hospice Medicare expenditures in persons with dementia
versus cancer; 2) Assess the impact of 2016 Payment Reform on hospice disenrollment patterns and
outcomes in persons with dementia versus cancer; and 3) Characterize experiences and views of hospice care
for PWD in a diverse set of caregivers of PWD and hospice staff from a variety of organizational roles.
Knowledge from this study is necessary to the continued refinement of hospice policies and transforming end-
of-life care to meet the needs and trajectories of PWD and their caregivers, and will provide critical training for
Dr. Lauren Hunt’s development as a leading researcher in hospice and end-of-life care for PWD.

Public health relevance
NARRATIVE Although almost half of the over 1.5 million Medicare beneficiaries who enroll in hospice each year have Alzheimer’s Disease and Related Dementias (ADRD), hospice is poorly suited to the needs of people with dementia. Hospice care for people with dementia is both more expensive and lower quality than for other populations, such as those with cancer. The proposed study will evaluate how recent changes in the way Medicare pays for hospice impacts the quality and costs of care for hospice enrollees with dementia compared to those with cancer, which will help determine how to provide the highest-value hospice care for the hundreds of thousands of people with dementia enrolled in hospice every year.